Translational Research to Prevent and Control Global Infectious Diseases (Translational Global Infectious Diseases Research Center, TGIR).

ABSTRACT
The human gut microbiota is a modifiable effector of many physiological processes including immune response.
Live attenuated oral vaccines stimulate immunity at the gut mucosal surface, a microenvironment teeming with
diverse microbial taxa living in complex interacting and dynamically evolving communities. Evidence suggests
that the gut microbiome is responsible for some of the differences observed in oral vaccine response that
challenge disease prevention efforts in resource-limited settings, but many knowledge gaps remain.
Understanding the effects of the gut microbiome on oral vaccine response is key to overcoming two of the most
critical problems in pediatric global public health: polio eradication, which, if successful, would be among the
greatest global public health achievements; and rotavirus, a vaccine-preventable cause of diarrhea still
responsible for well over 100,000 pediatric deaths per year. We have assembled an interdisciplinary team of
current and former COBRE Project Leaders from University of Vermont’s Translational Global Infectious
Diseases Research (TIGR) Center and Dartmouth College’s Center for Molecular Epidemiology. This team will
take on a new project aimed at evaluating the role of the gut microbiome in oral vaccine take and response that
builds upon existing research themes and leverages the resources of both centers. Our new collaborative project
will create rich metagenomic data sets of longitudinal stool sampling from existing vaccine trials with multiple
vaccine response biomarkers already measured. To these data, we will apply established biostatistical
approaches and develop and apply a novel machine learning approach to identify features of the microbiome
related to development of protective and mucosal immune responses. This project will result in data that can
inform subsequent long-term investigations of major ongoing questions in oral vaccine response as a function of
the complex systems at the microbiome-host interface.

Public health relevance
Project Narrative Suboptimal immune responses to live-attenuated oral vaccines such as oral rotavirus (ORV) and polio (OPV) vaccines threaten critical public health efforts, including reductions in diarrheal disease burden and global polio eradication efforts. Mounting evidence suggests a key role for the intestinal microbiota in modulating mucosal immune responses. This project will use well-characterized samples from ORV and OPV vaccine trials to provide crucial information on the impact of the intestinal microbiota on live-attenuated oral vaccine replication and subsequent immune responses with the ultimate goal of informing low-technology strategies to improve oral vaccine performance in critical target populations, namely children and young adults in low- and middle-income countries.